Genetic and hypoxic control of a lncRNA axis orchestrates endothelial reprogramming in pulmonary hypertension

Background and Hypothesis: Pulmonary hypertension (PH) is a deadly disease, where Group 1 PAH and
Group 3 PH are driven by hypoxia, HIF-2, and non-coding RNAs. We found that the lncRNA KMT2E-AS1 is
up-regulated in Groups 1/3 PH and is induced by HIF-2. This lncRNA gene neighbors KMT2E, a gene
controlling histone 3 lysine 4 trimethylation (H3K4me3) and chromatin remodeling. In pulmonary endothelial cells
(ECs), KMT2E-AS1 stabilizes KMT2E to increase H3K4me3, thus driving HIF-2-specific metabolic and
pathogenic alterations. The G-allele of single nucleotide variant (SNV) rs73184087 within KMT2E is associated
with risk of developing Group 1 PAH (in discovery/validation cohorts and a meta-analysis of 2,181 PAH vs.
10,060 controls). rs73184087 also displays more avid allele (G)-specific association with HIF-2 leading to
induction of this lncRNA-KMT2E pair. A mouse deficient in the conserved lncRNA sequence is protected against
Groups 1/3 PH; this is phenocopied by inhibition of histone methylation in PAH rats. We postulate that the
KMT2E-AS1/KMT2E axis is a central lynchpin in pathogenic reprogramming in ECs, promoting PH. Aim
1) Define the allele-specific role of the KMT2E SNV rs73184087 in controlling HIF-2-dependent EC
lncRNA-KMT2E expression and PH pathophenotypes. Using ECs derived from genome-edited inducible
pluripotent stem cells (iPSC) as well as primary lung ECs carrying rs73184087 A and G alleles, we will determine
if (G) increases lncRNA-KMT2E by more HIF-2 binding and drives more severe EC phenotypes. We will also
pursue expression quantitative trait loci (eQTL) analysis in blood samples from PAH patients
(discovery/validation cohorts) and PAH lung tissues carrying A and G alleles of rs73184087. Aim 2) Define the
role of this lncRNA-KMT2E axis and H3K4me3 in promoting PH in vivo. We will quantify Groups 1/3 PH
severity in rodents after EC-specific knockdown of this lncRNA vs. lncRNA+KMT2E and after AAV-driven EC-
specific expression of lncRNA vs. lncRNA+KMTE2. We will also determine if MM-589, a specific H3K4me3
inhibitor, reverses PAH in rats. Thus, we aim to determine if lncRNA+KMT2E together are necessary and
sufficient to drive Group 1/3 PH and if PAH is dependent upon H3K4me3 activity, thus offering a new epigenetic
PH therapy. Aim 3) Define the causative role of the G allele of rs73184087 on pulmonary vascular
remodeling and PH in vivo. Culturing human precision cut lung slices, we will determine if the rs73184087 G
allele drives vascular remodeling via regulation of the lncRNA-KMT2E axis and H3K4me3. We have also inserted
the human rs73184087 G vs. A allele in mice and will use these “humanized” mice to study these alleles in vivo.
With these 2 unique platforms, we will determine if the G allele drives HIF-2-specific EC phenotypes and PH.
Significance: We plan to shift paradigms of lncRNA biology in PH, via defining the links of hypoxia to epigenetics
and metabolism and by introducing new epigenetic therapies. By establishing the causative role of rs73184087
in PH, we are poised to leverage functional genomics to gain mechanistic insight in PH specifically for humans.

Public health relevance
Project Narrative In this proposal, we aim to establish the role of a specific ribonucleic acid molecule called KMT2E-AS1 that we believe promotes the development of a deadly yet enigmatic disease of the blood vessels in the lung, pulmonary hypertension (PH). We also will pursue evidence that specific changes in our DNA control the expression of this molecule and increase the risk of PH for those individuals. If successful, our work will set the stage for a new era for medical care of PH patients, whereby therapies that target this molecular pathway can be deployed to specific individuals with the highest likelihood of a positive response.